Measuring Lifelong Multimorbidity with Patient Perspectives: Implementing and Visualizing the Cumulative Burden Methodology Across Cohorts

PROJECT SUMMARY/ABSTRACT
Background: Multimorbidity, defined as the co-occurrence of two or more physical or mental chronic illnesses,
is prevalent and rising globally. New measures of multimorbidity that provide unique insights into the spectrum,
pattern and magnitude of multiple co-morbid conditions are needed. Current measures fail to provide adequate
context from which to design, evaluate, and implement multilevel clinically-relevant interventions.
Objective: In response to PAR-20-179, we propose to develop, visualize and apply a modular suite of novel
measures and tools to address the critical limitations currently impacting multimorbidity outcomes research.
Specific Aims: (1) Develop personalized cumulative burden measures, over various stages of the life-course,
based on patient perspectives using condition-weighted burden weights and risk factors; (2) Create a suite of
web-based visualizations for use by any type of cohort; (3) Apply the cumulative burden to an independent
cohort of sickle cell disease patients to test implementation and guide future dissemination to other cohorts.
Study design: Two novel measures, which built on our existing cumulative burden framework, will be
developed using data from the St. Jude Lifetime Cohort (SJLIFE) study, a large clinical cohort of pediatric
cancer survivors. First, we will develop a personalized measure of multimorbidity risk for an individual using a
regression framework of the Poisson process to provide insights into lifelong variations in patterns and
magnitude of multiple chronic conditions and associated key risk factors. Second, we will implement burden
weights, a set of condition-specific weights derived from utility weights (which we will also calculate) using
SJLIFE data in order to incorporate patient perspectives. To use/share the metrics, the Agile approach to
software development will be employed to create dynamic, interactive web-based visualizations. Finally, using
the consolidated framework for implementation research, we will apply the cumulative burden method to study
multimorbidity in a second cohort comprised of adults and children with sickle cell disease in order to advance
national research priorities and study how others may our innovative measures to their cohorts.
Significance: Our cumulative burden measure was created to overcome some of the pressing difficulties with
current multimorbidity measures identified by PAR-20-179. This proposed study seeks to build on our prior
work by incorporating personalized risk prediction and patient-reported outcomes. Additionally, we recognize
that developing new measures and publishing our methods are insufficient to ensure broad use and impact. To
support effective implementation and dissemination, we will create visual tools that help investigators share
cumulative burden results and study the barriers and enablers of their application using an implementation
science approach. We anticipate our work will yield a suite of visualization templates and modular applied
method resources that will enable clinicians, researchers, advocacy groups, and policymakers an opportunity
to shed light on the growing problem of multimorbidity affecting nearly every sub-group of our society.

Public health relevance
PROJECT NARRATIVE Commonly applied methods to measure and analyze multimorbidity fail to provide adequate context and technical support from which to design, evaluate, and implement multilevel clinically-relevant interventions as indicated by the recently announced PAR-20-179 (Advancing Research to Develop Improved Measures and Methods for Understanding Multimorbidity). To address this gap, we propose to build on our prior novel work designing the cumulative burden measure of multimorbidity and: (1) develop patient-level personalized risk- prediction, based on predefined risk factors and “burden weights,” a condition-specific, patient-derived health- related quality of life metric designed to incorporate patient perspectives; (2) create visualization tools to facilitate sharing of cumulative burden data, from any cohort, broadly across different stakeholder audiences; (3) study, for the first time, chronic multimorbidity in a highly vulnerable population of pediatric and adult sickle cell patients while simultaneously examining the barriers and enablers that impact effective implementation of the cumulative burden measures in an unrelated, non-cancer clinical population. We anticipate our work will yield a suite of visualization templates and modular applied method resources in order to support implementation within a diverse number of cohort studies with the ultimate goal of assisting health system planning and improving understanding by clinicians, researchers, advocacy groups, and policymakers about the growing problem of multimorbidity affecting nearly every sub-group of society.